Technology Research in Chronic & Critical Illness

PROJECT SUMMARY ABSTRACT
The use of technology to monitor health, deliver health care and manage chronic and critical illness is
becoming more and more pervasive. Technology is increasingly touted as transforming health care. The
speed at which the technology field is advancing, combined with the burgeoning number of elders and
persons living in the community with complex illnesses and disabilities, and undeniable health inequities,
make it imperative that nurse scientists be prepared to examine the vital role of technology and clinical
data science in promoting better patient health outcomes within an interdisciplinary context. The
overarching goal of this training program remains to provide rigorous research training and
interdisciplinary culturalization to build nursing science aimed at promoting health, managing illness,
reducing disability, and enhancing quality of life through the aid of technology and clinical data science.
For this renewal we now add a greater emphasis on leveraging technology, clinical data analytics and
design-justice to reduce health disparities and promote health equity for vulnerable populations due to
social inequalities. Based on the growing need for nurse researchers to lead interdisciplinary teams and
contribute their unique domain expertise to these rapidly growing fields the specific aims of the training
program are to provide: 1) the theoretical and conceptual foundations to support the development of a
program of research that examines ways that technological solutions can be used to address unmet
clinical needs by enabling the prevention, detection, prediction, or management of health-related
problems, 2) the methodological skills to combine nursing domain knowledge and emerging clinical data
science strategies to better understand complex health phenomena, 3) the knowledge and skill to
incorporate equity and justice in designing technology and clinical data science studies in order to mitigate
social inequalities and health disparities, while promoting health equity across groups and vulnerable
populations and 4) skills to lead interdisciplinary teams to conduct research of impact that propels
technology solutions and clinical data science along pathways of translation into practice or
commercialization. Funding is requested to continue the program for five years to support three
predoctoral and two postdoctoral trainees per year. Clearly, nurse researchers need to be able to examine
the effectiveness, as well as the appropriateness, acceptability, and adherence of patients and providers
to high-tech health solutions and collaborate with the multiple disciplines that contribute to such efforts.
Unquestionably, this program will enable nurse trainees to be well-positioned to conduct innovative, state-
of-the-art research in this growing field.

Public health relevance
PROJECT NARRATIVE The use of technology to deliver health care and manage chronic and critical illness is becoming increasingly pervasive. The overarching goal of this T32 (Technology Research in Chronic and Critical Illness) is to provide rigorous research training and interdisciplinary professional socialization to build nursing science aimed at promoting health, managing illness, reducing disability and enhancing quality of life through the aid of technology and clinical data science. This program will enable nurse trainees to be well-positioned to conduct innovative, state-of-the-art research in this growing field based on principles of design-justice.